Architecture of inhibitory G protein signaling in the hippocampus

SUMMARY
Dysregulation of inhibitory G protein-dependent signaling, including signaling controlled by the GABAB receptor
(GABABR), is implicated in many neurological disorders and diseases. In the hippocampus (HPC), GABABR
exerts much of its inhibitory influence by activating G protein-gated Inwardly Rectifying K+ (GIRK/Kir3) channels
and by inhibiting Adenylyl Cyclase (AC). We have shown that GABABR-GIRK signaling in the HPC is modulated
by Regulator of G protein Signaling (RGS) proteins of the R7 sub-family, which sharpen the timing and dampen
the sensitivity of this signaling pathway. The R7 RGS sub-family includes RGS6 and RGS7, which form stable
complexes with G5. Genetic ablation of RGS7/G5 complexes in mice profoundly alters GABABR-GIRK
signaling, disrupting synaptic plasticity and HPC-dependent behaviors. R7 RGS/G5 complexes can also
associate with adaptor proteins, including the small palmitoylated protein R7BP and an orphan Class C GPCR
(GPR158). Our recent work suggests the intriguing prospect that discrete R7 RGS/G5 complexes, together with
R7BP and GPR158, play an essential role in the selective routing of GABABR signals to GIRK channels or AC.
These findings fuel our central hypothesis that R7 RGS/G5 complexes and their adaptors orchestrate the
assembly of inhibitory "signalosomes” – distinct physical and/or functional arrays of receptors, G proteins, RGS
and related proteins, and effectors – to ensure the dedicated and selective regulation of effector enzymes and
ion channels by GABABR. To test this innovative hypothesis, we propose a multi-disciplinary program with two
AIMs: 1) Identify mechanisms mediating GABABR-effector signaling dynamics and compartmentalization. We
will employ loss- and gain-of-function/rescue genetic manipulations in HPC pyramidal neurons, along with
electrophysiological and real-time optical assessments of GABABR-effector signaling, to test the prospect that
discrete R7 RGS/G5 complexes and their adaptors, working in concert with their inhibitory G protein substrates,
orchestrate the assembly of distinct and dedicated GABABR-GIRK and GABABR-AC signalosomes. 2)
Interrogate the organization of the GABABR-GIRK signalosome. Leveraging insights derived from our recent
crystal structure of RGS7/G5 and associated predictive modeling, we will use cell-based biochemical and
optical reporter assays, as well as orthogonal biochemical reconstitution approaches, to test hypotheses related
to interactions and interfaces among GABABR-GIRK signalosome elements. Structural insights into GABABR-
GIRK signalosome assembly will then be exploited to probe the functional relevance of specific interactions.
Summary: Our efforts will reveal whether R7 RGS/G5 complexes and adaptors orchestrate selective signaling
between GABABR and its effectors. This project will yield new mechanistic insights into the functional and
physical compartmentalization of GABABR-effector signaling, knowledge that can be used to design novel
therapeutic interventions for neurological disorders and diseases characterized by aberrant GABABR-dependent
signaling.

Public health relevance
NARRATIVE Dysregulation of inhibitory signaling is implicated in a wide array of neurological disorders and diseases, including those with cognitive and/or affective components. The goal of this project is to investigate the role of a family of modular regulatory complexes and related factors that shape the strength, sensitivity, and temporal precision of a prevalent form of inhibitory signaling in neurons. Successful completion of this project will yield new insights that could be leveraged to develop novel therapeutic approaches for neurological problems characterized by aberrant inhibitory signaling.